Behavioral and Neural Bases of Combining Oxytocin and Naloxone for Optimally Enhancing Interactive Social Attention

Project Summary
Several clinical trials have found that intranasal oxytocin (OT) treatment is not practically viable in its current
form for improving core social symptoms in autism spectrum disorders (ASD). The current intranasal OT
treatment has been criticized for its often weak and inconsistent effects, demanding an important need to explore
new ways to improve its efficacy and reliability in modulating the OT system. While much less studied, the central
opioid system has also been implicated in ASD based on the opioid dysregulation found in certain cases of ASD,
as well as the well-known modulatory effects of opioid agonists, such as morphine, and its receptor antagonists,
such as naloxone (NAL), in regulating social behaviors. In this translational non-human primate proposal, we will
investigate a new alternative therapeutic option in improving core social functions by exploiting the robust
regulatory relationship between the central OT and opioid systems. Our pharmacological study in non-human
primates recently provided a proof of concept of this combined pharmacological approach in more effectively
modulating social attention. The combined intranasal administration of OT and NAL (OTNAL) enhanced
spontaneous social attention and contingent gaze dynamics following interactive eye contact over and beyond
the summed effects from administering OT alone and NAL alone, indicating a combinatorial benefit of OTNAL.
Capitalizing on this finding, we now propose to determine the optimal doses of OT and NAL in the combined
OTNAL format, its corresponding cerebrospinal fluid markers of successful OTNAL interventions, as well as the
neurophysiological markers underlying the combinatorial benefits in the domain of social attention. We will first
obtain comprehensive dose-response functions for the OTNAL intervention during spontaneously occurring real-
life social gaze interactions and assess the corresponding changes in cerebrospinal fluid OT levels due to
OTNAL compared to other conditions (Aim 1A, 1B). We will then study how neural activity patterns within and
across two key brain nodes in social processing, the amygdala and the anterior cingulate cortex, are impacted
by OTNAL (Aim 2). Finally, we will test causal contributions of these two regions for the OTNAL effects by
blocking OT-binding receptor types focally in these areas (Aim 3). The results from this work will offer novel
mechanistic insights into the combined pharmacological approach using OTNAL to more vigorously promote
social engagements in the primate brain. Such results will help set the stage for translating the combinatorial
benefit of using intranasal OTNAL for more effectively and reliably reducing core social symptoms in ASD.

Public health relevance
Project Narrative Intranasal oxytocin treatment, in its current form, is not viable as an effective therapeutic option for treating social impairments in autism spectrum disorders. A combined pharmacology approach of intranasally co- administering an opioid receptor antagonist, naloxone, and oxytocin can drastically amplify the positive effects of either drug independently. In this proposal, we will determine a set of optimal doses for this combinatorial intervention and investigate how it leads to a greater enhancement of social processing in key brain regions using a non-human primate model of live social gaze interaction.